Exploring Factor H recruitment by Treponema pallidum to avoid complement-mediated killing

ABSTRACT
In several high-income nations, including the United States, infectious syphilis has been resurgent
for over two decades now, while syphilis is still endemic in low- and middle-income countries. Syphilis is
therefore still a public global health concern, particularly in consideration that it can lead to neurological
sequelae such as dementia and stroke-like syndrome, as well as cardiovascular manifestations potentially
leading to death. Furthermore, every year, about half a million pregnancies are adversely affected by
congenital transmission of the pathogen. The partial success of recent syphilis control campaigns promoted
by the CDC and WHO clearly highlights the necessity of devising novel ways to control this serious infection.
Improving our understanding of syphilis pathogenesis and the virulence factors that allow the syphilis agent,
Treponema pallidum subsp. pallidum (Tp) to establish infection and persist in the host despite a robust
immune response might be the key to new control strategies.
A key aspect of the pathogenesis of early syphilis is the hematogenous dissemination of Tp to
virtually every bodily organ. However, to reach distant tissues via the bloodstream, Tp must avoid killing by
the rapid activation of the complement alternative pathway (AP). Complement evasion is a virtually
unexplored topic in syphilis research, and yet it is critical to understanding pathogen persistence. To escape
killing, many pathogens employ binding factors to recruit the host complement inhibitor Factor H (FH) from
body fluids, thus hijacking its host-protecting function. We demonstrated that also Tp recruits human FH via
a 43.1 kDa FH binding protein, and that recruitment occurs by recognizing the FH short consensus repeats
(SCR) modules 19-20. Removal of sialic acid from the Tp surface with neuraminidase did not affect FH
recruitment by the 43.1 kDa protein. However, studies from the 80’s by T.J. Fitzgerald implied that
sialylation of still unidentified macromolecules on Tp surface contributes to evading the AP, which is
consistent with the fact that FH SRC19-20 can be recruited by both sialic acid and binding protein(s).
In this proposal, we aim to identify the 43.1 kDa ligand. Additionally, we will test the hypothesis that
Tp mutants lacking the 43.1 kDa protein or the gene encoding the pathogen’s NeuB sialic acid synthase will
be more susceptible to killing by the AP and impaired in their ability to disseminate and cause infection in
the rabbit model.
If successful, these studies will provide our research community with information about a novel
virulence factor of Tp and mutants of this pathogen to be used in comparative studies, in addition to a better
understanding of syphilis pathogenesis.

Public health relevance
PROJECT NARRATIVE Syphilis affects millions of people worldwide, and its global rates are on the rise. Syphilis causative agent, Treponema pallidum (Tp), can cause severe neurological sequelae, and individuals with syphilis are at higher risk of transmitting and acquiring HIV. A better understanding of syphilis pathogenesis and the molecular mechanisms allowing the syphilis agent to survive complement-mediated killing will help devise new methods to control this serious infection.